Enhancing the Cloud-Readiness of Perceptual Computing Through Data Standardization Software

ABSTRACT
Behavioral science is in the midst of a paradigm shift away fromhuman judgment and toward rigorous perceptual
computing (PC) and investment in human predictive analytics. As a part of three separate NIH R01s (including
the Parent R01 [MH125958]), our team is developing open-source software tools to exquisitely measure social
and emotional behavior, including tools to quantify facial movements, body actions, and language.
Unfortunately, the field of perceptual computing currently has no agreed-upon standard for organizing,
maintaining, and curating large audio-visual datasets, and the myriad data streams that accompany them (for
example, simultaneous psychophysiology recordings from wearable devices). The absence of such a standard
is a major impediment to innovation in perceptual computing, as it hinders the development of large -scale
computational pipelines and algorithm optimizations that cloud applications require. The purpose of this
Supplement is to directly address this problemthough the creation of acommon data structure ready for adoption
and iteration by the field of PC, along with a set of basic tools for working with data that follow this structure. The
parent R01 for this Supplement is an ideal context in which to develop such a standard, as it involves the
collection of more than 3000 individual audio-visual files across two sites (The Children’s Hospital of Philadelphia
and Baylor College of Medicine). In other words, the parent R01 is a microcosm of the larger challenge facing
the field – how to effectively and seamlessly integrate separate datasets in ways that supports robust and highly
replicable analysis paths. This Supplement to our R01 will address this challenge by developing an open-source
Sensor Data Structure (SDS) – a data generation, storage, and basic processing standard for use by the
perceptual computing community – along with open-source software tools and Container environments to
generate and validate data. We propose to parallel the achievements by highly successful NIH -supported
Biomedical Imaging Data Structure (BIDS), which was developed to address an analogous problem in the field
of brain imaging (e.g., the need to harmonize and curate large multicenter datasets). Although the Parent R01
is staffed for collecting and analyzing data, this Supplement would provide three new deliverables, all
implemented via the addition of software engineer with industry experience: 1) creation of the data structure, 2)
creation of a Python module and Container environment for implementing the standard, and 3) posting and
monitoring these two deliverables publicly on GitHub. This is acritical step toward our ultimate goal of developing
PC tools that are “cloud-ready”, and in widespread use by the PC community.

Public health relevance
PROJECT NARRATIVE The Parent R01 for this Supplement application involves the development of open-source software tools to exquisitely measure social and emotional behavior, including tools to quantify facial movements, body actions, and language. Unfortunately, the field of perceptual computing currently has no agreed -upon standard for organizing, maintaining, and curating large audio-visual datasets, and the myriad data streams that accompany them (for example, simultaneous psychophysiology recordings from wearable devices). The purpose of this Supplement is to directly address this problem though the development of a common data structure (called Sensor Data Structure, or SDS) ready for adoption and iteration by the field of PC, and a set of basic tools for working with data that follow this structure.